Dev Pilot Projects, Cross BETRNet, and other Cross BETRNet Activities

The overall objective of the Translational Research Center - F Developmental Research Program (TRCFDRP) is to develop innovative and diverse approaches to focus on Barrett's esophagus and esophageal adenocarcinoma translational research across the spectrum from etiology through prevention screening, diagnostics, and therapeutics. The TRCFDRP will provide 1) financial support, 2) Bioinformatic support 3) TRC-F resources and 4) intellectual oversight and advice for pilot research projects and investigators. Funds for development of pilot research projects are critical to ongoing development and enhancement of the TRC-F and the TRC-F will allocate $150,000 per year for years 2-5 for pilot projects to be used $50,000 per year for pilot projects from within the TRC-F and $100,000 per year for cross center projects. Within-center and Cross Center Pilot Projects will be solicited, reviewed and awarded by the BETRNet Steering Committee on a merit basis with evaluation criteria based on scientific merit, impact, significance, innovation, transdisciplinary characteristics, translational potential, with great significance attached to the potential for the contribution to enhance and extend BETRNet projects as well as the potential for developing into independent research projects. In addition, cross-center pilot projects will consider potential contribution of applications to increase sample size, provide complimentary skills, resources and/or expertise or collaborations with other Translational Research Centers or other multi-institutional cooperative groups. Emphasis will be placed on supporting new investigators as well as established investigators with new approaches. For meritorious proposals from individual basic or clinical investigators, the TRCFDRP leadership group will identify complementary translational investigators to serve as advisors. An innovative approach that we will initiate to engage expertise from both inside and outside the TRC-F will be to post on the Cancer Center website and the national BETRNet website, a series of Research Opportunities in which each TRC-F project will provide a list of research questions, resources, expertise, etc. that will be available for collaborative pilot project research.